Cortical mechanisms underlying aberrant auditory perception

The present proposal will utilize an animal model and in vivo imaging techniques to determine whether
altered cell-specific activity or disrupted neurotransmitter signaling in the auditory and frontal cortices underlie
tinnitus and hyperacusis perception. Tinnitus (i.e., ringing in the ears) and hyperacusis (hypersensitivity to
sound) are two highly prevalent and often debilitating auditory conditions. At present, the neural basis of these
conditions remain unresolved, which has significantly hindered our ability to develop effective treatment
strategies for ameliorating their perception. Prior studies suggest that tinnitus and hyperacusis may arise as a
consequence of a maladaptive imbalance between excitation and inhibition in the auditory cortex following
hearing loss. Additionally, top-down gating of this aberrant auditory activity by higher-level brain regions, such
as the frontal cortex, has also been implicated as a contributing factor to tinnitus/hyperacusis perception.
However, we currently lack an understanding of how altered activity of specific neuron sub-types and changes
in neurotransmitter signaling within the auditory and frontal cortices differentially contribute to the generation of
tinnitus, hyperacusis, or both conditions. The present proposal will use a validated operant conditioning tinnitus
behavioral paradigm co-developed by the PI and a sound-avoidance hyperacusis task, combined with
advanced in vivo imaging techniques to advance our understanding of the neural basis for these auditory
conditions. Using cell-specific calcium imaging via miniscopes, Aim 1 will investigate the contribution of altered
pyramidal cell activity in the auditory and frontal cortices to tinnitus/hyperacusis perception. In Aim 2, fiber
photometry recordings of neurotransmitter signaling in the auditory and frontal cortices will be used to
determine whether altered glutamatergic/GABAergic signaling underlie perception of these auditory conditions.
Ultimately, results from these experiments are expected to have high impact because they will identify potential
cell-specific and neurotransmitter-specific therapeutic targets for treating tinnitus and hyperacusis perception.
Dr. Sarah Hayes, Au.D., Ph.D. is a clinician-scientist dedicated to providing audiological care for
patients with tinnitus and hyperacusis, and advancing our understanding of the neural basis for these disorders
through her research. This proposal leverages her extensive experience in animal behavioral assessments of
auditory disorders and electrophysiological recordings in rodents, to provide her with the opportunity to develop
new skills in advanced in vivo imaging techniques, while moving the field forward in elucidating the neural
basis for tinnitus/hyperacusis. Additionally, the technical expertise that she will acquire through this proposal
will help establish a scientific platform for her to identify and assess therapeutic targets and treatments for
tinnitus and hyperacusis. Collectively, the expertise of her mentorship/advisory team, combined with the vibrant
collective of hearing, balance, and neuroscience researchers at the University of Rochester provides an ideal
setting for Dr. Hayes to develop into a successfully funded independent investigator.

Public health relevance
Tinnitus (e.g., ringing in the ears) and hyperacusis (hypersensitivity to sound) are highly prevalent auditory disorders for which we lack effective treatments. The proposed research in an animal model will advance our understanding of the neural basis of these conditions by investigating how specific neuron sub-types and neurotransmitter systems in the cortex contribute to their development. The results from these experiments will identify potential therapeutic targets for treating tinnitus and hyperacusis perception.